New upstream targets for HIF-1a-mediated regeneration in young and aged animals

Project Summary/Abstract
The ability to regenerate tissue in mammals has remained elusive. While the use of stem cell populations in
the context of bio-scaffolds has shown promise as a potential means of replacing lost, damaged, or diseased
tissue, significant challenges remain. An alternative approach is to attempt to evoke a classical in situ
regenerative response emulating that seen in lower species such as newts. While this trait was thought to be
lost in evolution, our observation (Heber-Katz) that the MRL mouse and related strains have a significant
spontaneous regenerative capability demonstrates that the trait is retained in mammals. Studies over the past
almost 25 years have culminated in the identification of the HIF-1α (hypoxia inducible factor) pathway as the
central actor regulating regeneration in mice. The up-regulation of HIF-1α in non-regenerating mice have
allowed these mice to regenerate ear holes with cartilage and hair follicles; and jaw bone and associated soft
tissues after induced periodontal disease (PD). In both cases, a classical regenerative de-differentiation
response was seen. This was achieved using the PHD inhibitor 1,4-DPCA in novel injectable biomaterial
constructs (Messersmith) leading to the stabilization of high levels of HIF-1α in vivo. The mechanisms that
were identified in the PD model involved inflammatory cytokines, bone remodeling osteoblasts, Tregs and
CXCR4 expression. Using a CXCR antagonist, AMD3100, the regenerative response could be blocked and
supports the need for Tregs and certain stem and myeloid cells.
In this current proposal, we provide preliminary results showing that two new upstream target
molecules DEL-1 (Hajishengallis) and PAR1 (Heber-Katz) with known agonists have been identified which
affect HIF-1α expression. We will explore the role of HIF-1α and these two molecules in the regenerative
response in young and aged mice using both the ear hole model and the PD model.
We will use advanced molecular design to produce a biomaterial capable of achieving single dose
and local delivery vs the current three dose delivery system. In addition to yielding a novel soft and bone tissue
regeneration therapy, we believe that this system provides an impressive landscape of phenomena that will
yield important mechanistic information about in-situ regenerative responses in oral tissues.
In Aim 1, we will create new biomaterials to yield local drug release using mucoadhesive polymers; in Aim 2,
we will examine the role of the anti-inflammatory molecular DEL-1 in aged mice with PD, a molecule having
direct affects on HIF-1α levels; and in Aim 3, we will examine the role of PAR1, another molecule which affects
HIF-1α levels in the ear hole and periodontal injury models, in both young and aged mice.

Public health relevance
Project Narrative Periodontal disease is the main cause of tooth loss and takes a significant toll on patient health in both young and old and has a major economic impact. Achieving regeneration of oral tissues such as bone and periodontal ligament that are affected by periodontal disease in aged individuals using a drug delivered from an injectable biomaterial would be of major importance in dental medicine and health in general.